FY23. SBIR TOPIC 167 PHASE I: AN ARRAY-BASED MULTIPLEX IMMUNOASSAY FOR POSTMORTEM TOXICOLOGY SCREENING

FY23. SBIR TOPIC 167 PHASE I: AN ARRAY-BASED MULTIPLEX IMMUNOASSAY FOR POSTMORTEM TOXICOLOGY SCREENING